Epigenetic and Non-epigenetic Role of SIRT1 in Fluoride-induced Cell Stress Administrative Supplement.

This is an application to the Administrative Supplements for Continuity of Biomedical and Behavioral Research
Among First-Time Recipients of NIH Research Project Grant Awards (NOT-OD-23-032), granted for the PI's (Dr.
Maiko Suzuki) parent R01 grant (R01DE027648) entitled “Epigenetic and non-epigenetic role of SIRT1 in
fluoride-induced cell stress”. The PI's overarching research objective in the dental-oral-craniofacial field is to
identify environmental factors related to craniofacial pathophysiology and to develop novel preventive and
therapeutic strategies for environmental factor-associated oral diseases, including tooth malformation,
periodontitis and oral cancer. To attain the objective, in this supplement, the PI will develop the current R01
project into fluorinated compounds (per- and poly- fluoroalkyl Substances; PFAS), which are newly highlighted
as environmental pollutants. PFAS are a large group of artificial fluorinated organic compounds that have
generated increased public attention due to their toxicity and adverse health effects. The molecular mechanisms
of PFAS effects on dental-oral-craniofacial pathophysiology are largely unidentified. In the parent R01 award, we
focus on the molecular mechanisms of fluoride on enamel development. Our preliminary results demonstrated
that, as well as fluoride, fluorinated organic compounds PFAS could cause adverse effects on enamel formation
in vitro and in vivo. Recent studies have demonstrated the association between PFAS exposure and some types
of cancer. However, the PFAS effects on Head and Neck Cancer (HNC) are largely unidentified. In this
supplement, we propose to develop the parent research project into PFAS-mediated HNC pathology. The
objective is to determine the biological effects of PFAS on HNC in vitro. Our preliminary data suggest that PFAS
could promote HNC invasiveness and metastasis. We preliminary discovered that perfluorooctanoic acid (PFOA;
a most studied PFAS) increased the expressions of epithelial-mesenchymal transition (EMT) markers and
promoted cell migration (wound healing assay) in a murine squamous cell carcinoma cell line (SCC7) in vitro.
SCC7 has been used as an oral cancer and head and neck cancer model in vitro and in vivo. Our previous study
demonstrated that fluoride and PFOA increased ROS generation to cause oxidative stress in ameloblast-like
cells. Based on our previous studies and preliminary data, we hypothesize that ROS may play a critical role in
PFOA-mediated cancer EMT and cell migration. This hypothesis will be tested by the Aim: To determine the role
of ROS in PFOA-mediated EMT and cell migration in murine and human oral squamous cell cancer (OSCC) cell
lines in vitro. Upon successfully completing this proposed study, the results will provide new insights that PFAS
could be considered a possible metastatic factor in HNC. Findings from this supplement and parental projects
will improve our understanding of the health effects of fluorinated environmental factors (fluoride and PFAS) on
enamel malformation and head and neck cancer pathophysiology.

Public health relevance
Project Narrative Organofluorine compounds, PFAS (per- and polyfluoroalkyl substances) have generated increased public attention due to their ubiquitous presence in the environment and their association with toxicity, especially as a potential risk factor for cancer. This administrative project aims to identify the possible PFAS effects on head and neck cancer invasiveness. The results could provide insight into the potential association between PFAS and head and neck cancer risks, especially for personnel who are occupationally exposed to higher amounts of PFAS.